Impacts of genetic variation in the Fc gamma receptor locus on functionality of natural killer cells and monocytes

ABSTRACT
IgG Antibody (Ab) based therapeutics are becoming more common in treating several diseases, including
infections, autoimmune disorders, transplant rejection, and cancer. Abs contain two important domains; the Fab
domain mediates binding to a specific antigen, and the Fc domain of an antigen-bound IgG Ab then binds to
Fc-gamma receptors (FcRs) expressed on the surface of different immune cells (e.g. NK cells, monocytes)
and thereby initiates a broad array of effector functions related to target cell destruction, such as antibody-
dependent cellular cytotoxicity (ADCC) and antibody-dependent cell-mediated phagocytosis (ADCP). However,
Ab-based therapies are complicated by what appears to be suboptimal efficacy in a significant number of treated
patients. A potential cause for this variability in response to Ab treatment could lie in genetic differences
in the FcR locus, which is highly diverse genetically, with (at least) > 20,000 reported single nucleotide
polymorphisms (SNPs) plus additional copy number variations (CNVs). Considering the extreme genetic
complexity of the FcR locus, we have established a high-throughput assay to systematically screen for
functional SNPs in the FcR locus. Based on the existing literature and our own results, we hypothesize that
FcR polymorphisms modulate Ab functions across individuals, i.e., the same Ab but with different
efficacy, by differentially regulating expression patterns of FcRs in a cell type-specific manner. Here we
aim to systematically identify the functional impact of genetic variations in the FcR locus. Aim 1: Identify
functional SNPs in the FcR locus that regulate expression of FcRs in human effector cells, and regulatory
proteins binding to each SNP. Aim 2: Use the identified FcR SNPs and interacting proteins to derive predictive
models for ADCC and ADCP activities. Ab based immune suppressions are routinely used to prevent transplant
rejection and often function through ADCC and ADCP based mechanisms. We will enroll a group of 100
transplant patients in parallel with Aim 1, collect blood samples before transplant and measure their ADCC and
ADCP activities in vitro. We will build computational models that predict ADCC and ADCP activities in individuals
using their FcR genotypes alone, and together with other variables. Aim 3: Determine the impact of FcR
genotypes on the efficacy of Ab based immune suppression regimens. After receiving Ab based depletional
induction for transplantation, we will assess the contributions of these patients’ FcR genotypes and additional
variables to the differences in their depletion efficiency. The expected outcome is to systematically identify
functional SNPs in the human FcR locus and their impact on Ab based immunosuppression. This knowledge
will further contribute to differentiating mechanisms of antibody-mediated rejection in transplantation and its
treatment.

Public health relevance
NARRATIVE Antibody based therapeutics are becoming more common in treating diseases but with suboptimal efficacy in a considerable number of treated patients. We propose to systematically identify functional genetic variants in the FcγR locus and their contributions to the differences in antibody mediated functions. This may lead to potential strategies for patient stratification and novel targets and mechanisms to improve antibody based therapeutics.